Spatial dysregulation of the lipidome in Alzheimers disease human and mouse brain

Whereas lipidomics assays in peripheral blood are relatively well-established, the application of spatially-
resolved lipidomics in the brain is novel. Bulk lipidomics studies have revealed potential differences in lipid
metabolism across aging and disease, but the regional and cell type-specificity of these changes remains
unresolved. In particular, given that the brain comprises numerous cell types of multiple lineages with tightly
regulated spatial organization and inter-connections, it is likely the lipid profiles, metabolism, and dysregulation
are all dramatically non-uniform across the brain. Thus, we propose to provide a map of this non-uniformity in
brain tissue would move the field forward substantially in terms of having a universal reference, much as the
Allen mouse brain atlas revolutionized researchers' ability to query spatial patterns of gene expression in the
brain. We believe that a lipidomics atlas will be transformative in a similar way, especially given the increased
focus on lipid dysregulation in neurodegenerative disease. We will test the hypothesis that deficits in the acyl
chain remodeling pathway may underlie the changes in metabolic profile such as fatty acid metabolism and
functional effects mediated by genes ABCA7, PICALM and BIN1 which have recently been identified
associated with Late Onset AD genetic risk. Our continuing studies on phosphoinositide metabolism and the
gene network including Synaptojanin1 (Synj1) are highly relevant to PICALM, a phosphoinoistide binding
protein, and BIN1, also known as amphiphysin2, which interacts with Synj1 and is likely to mediate
phosphoinositide signaling. ABCA7 interestingly, has been shown to transport lysophosphatidylcholine (LPC) a
major biochemical intermediate of the Land's cycle and acyl chain remodeling. Recently, ABCA7
haplodefeciency has been shown to disrupt microglia function. It is clear that functional studies to understand
phospholipid regional brain distribution, cell specificity and roles in cell-specific functions are critical for gaining
understanding of these genes as well as the pathogenesis and disease progression of AD. Ultimately, we will
identify biomarkers based on lipids which are dysregulated in brain and show correlated (positive or negative)
dysregulation in plasma, which is tractable in the clinic. We hypothesize that re-programming of lipid
metabolism is likely to be based on early changes in the Lands Cycle, acyl chain remodeling. This early and
stereotypically altered metabolic shift in the lipid profile could ultimately be used for biomarker or therapeutic
target discovery in AD. Successful completion of these studies will lead to system-wide, biological insight into
the contribution of lipid metabolism to Alzheimer's Disease and validation of a lipid discovery platform which
can be applied to future studies for development of biomarkers as well as therapeutic targets.

Public health relevance
Over the past decade, it has become increasingly clear that the processing, turnover, and generation of lipids in the brain is altered in many aspects of brain disease. However, there is currently no brain-wide atlas of regional lipid distribution and lipidomics in the brain, which is relevant for the functional consequences of lipid metabolism and in the context of disease. Here, we propose to address this major gap by generating a mouse lipidomics reference atlas of the brain, and integrating it with the Allen Brain structural connectivity and gene expression atlases in mouse models of Alzheimer's disease and human brain.